Regulation of sex-specific development by transcription factors

Project Summary
Homologs of Drosophila Doublesex (Dsx), the Dsx, MAB-3 Related Transcription Factors (DMRTs), are known
to control gonad sexual dimorphism across the animal kingdom, from planaria and water fleas, to worms, flies,
mice and man. Patients with mutations in DMRT1 exhibit XY gonad dysgenesis and infertility, indicating that
DMRT1 is essential for male gonad development in humans. Given the universal nature of DMRT involvement
in gonad sexual dimorphism, a key question becomes how do these transcription factors regulate this process
and what are their target genes? Here we propose to study these questions using both genomic and
developmental approaches. In particular, a developmental process of high interest is the formation of the
gonad stem cell systems and the somatic cells that support the germline. In mammals, this process is highly
dimorphic as the testis has a stem cell system but the ovary does not. However, in many animals, both the
ovary and the testis have stem cell systems, since both sexes need to produce large numbers of gametes for
an extended period of life. These stem cell systems are also highly dimorphic between the sexes. Further,
gonads of many organisms have a somatic stem cell (SSC) population, in addition to the germline stem cells
(GSCs), and the SSCs produce differentiating daughter cells that nurture the developing gametes. For
example, the Cyst Stem Cells (CySCs) in the Drosophila testis interact with GSCs and produce Cyst Cells that
associate with differentiating germ cells, and so these cell types together perform a function similar to
mammalian Sertoli cells. Here, we propose to study how Dsx acts to control two key aspects of the male and
female stem cell systems, the stem cell niches and the male and female SSCs, using both developmental and
genomic approaches.

Public health relevance
Project Narrative Differences/Disorders of Sexual Development (DSDs) occur when proper sex-specific development of the gonads or other organs does not occur correctly. DSDs represent a significant human health concern since they result in infertility and other health problems. In this proposal we study the founding member of the Doublesex, MAB-3 Related Transcription Factor (DMRT) family, which control sex-specific development of the gonads across the animal kingdom and are mutated in human DSDs.